Probing the specificity and activity of the metazoan Integrator complex

Project Summary
Precise control of gene expression in response to external signals and cues is essential for organismal
development, growth, and homeostasis. A critical step in metazoan gene regulation involves pausing
RNA polymerase II (RNAPII) in early elongation and its controlled release into productive RNA synthesis.
Pausing of RNAPII consists of the association of pause-inducing factor NELF and the central scaffolding
protein SPT5, which maintain RNAPII stably within the promoter region while awaiting the signal for pause
release. Pause release is triggered by the kinase P-TEFb, which phosphorylates RNAPII and SPT5 to
cause the dissociation of NELF and promote productive elongation. However, our recent work
demonstrated that paused RNAPII can experience a different fate: it can be targeted by the Integrator
complex (INT), a multi-subunit transcription termination machine. INT association with paused RNAPII
drives promoter-proximal termination, with RNAPII releasing a short, non-productive RNA. In this way,
INT potently attenuates messenger RNA (mRNA) expression. Importantly, INT antagonizes RNAPII
pause release using two distinct activities: endonuclease-mediated cleavage of the nascent RNA and
phosphatase-dependent removal of stimulatory phosphorylation. Indeed, our recent work revealed that
INT recruits the protein phosphatase 2A (PP2A), directing its activity toward the elongation complex.
Studies in multiple model systems have demonstrated that mutation or depletion of INT subunits
activates stress-responsive genes, indicating a conserved role for INT in suppressing these pathways in
normal, healthy cells. Accordingly, mutations in INT have been associated with a large number of
diseases, with every one of the subunits in the INT complex being implicated in one or more
pathophysiological state(s). Improving our understanding of INT activity will thus provide invaluable
insights into mechanisms of diseases associated with INT mutations, such as blood, hepatic and gastric
cancers, and developmental disorders, including ciliopathies and aberrant neuronal migration.
The proposed research will address central questions that remain about INT function and
regulation. Specifically, Aim 1 will dissect the roles of the INT endonuclease and phosphatase modules
in gene regulation, assessing coordination between these modules and the requirement for each catalytic
activity across the repertoire of target genes. Given the established role of INT in attenuating stress-
responsive genes during normal cell growth, Aim 2 will determine how stress signaling can activate these
genes. In particular, we will investigate several potential models for INT inactivation by cellular stressors.
Our work shows the ‘Z3’ complex is an uncharacterized INT module, and, given its previous connections
to DNA/chromatin binding and transcriptional repression, Aim 3 will probe the role of Z3 in INT function.

Public health relevance
Project Narrative Normal human development and survival is contingent upon rapid and accurate gene control in response to environmental and developmental signals. The proposed work will elucidate how the Integrator complex regulates signal-responsive gene expression at a mechanistic level. The importance of this knowledge is underscored by the numerous human diseased states associated with Integrator mutation and dysfunction such as cancer, neuronal and blood disorders and developmental abnormalities.